Identifying the molecular networks regulating cilium assembly and signaling

Abstract: Primary cilia are essential organelles that mediate and integrate important signaling
pathways. Cilia-based signaling is therefore essential for the development of many tissues, and ciliary
dysfunction is linked to hereditary disorders. In spite of growing appreciation for the importance of
primary cilia, little is known about the signaling pathways that regulate the assembly and function of
these organelles. In previous studies, we identified a kinase, Tau Tubulin Kinase 2 (TTBK2), that is
essential for the initiation of ciliogenesis. We subsequently showed that TTBK2 is also required for the
stability and maintenance of the cilium, and thus serves as a critical molecular handle to dissect distinct
aspects of ciliary regulation. In addition to our work, independent studies also found that Ttbk2 is
mutated in a human hereditary ataxia, suggesting that TTBK2 and cilia are important for neuronal
function in vivo. The overall objective of this proposal is to define specific cellular requirements for
TTBK2 in ciliogenesis, and identify new components of TTBK2-dependent ciliary pathways. Based upon
our studies of Ttbk2 mutant mouse embryos and cells, as well as the links between Ttbk2 and a
neurodegenerative condition, our central hypothesis is that TTBK2 controls pathways that are critical
for both cilium initiation as well as cilium stability, and these pathways are in turn essential to maintain
neural function in the adult brain. To test this hypothesis, we propose the following aims: First, we will
take advantage of the requirements for TTBK2 at distinct steps of cilia regulation to identify additional
components of the networks that control cilium initiation as well as cilium stability. Our previous work
demonstrated that TTBK2 is essential for the recruitment of the intraflagellar transport (IFT) machinery
that assembles the cilium. We use live imaging to define how TTBK2 mediates IFT recruitment and
trafficking and also identify TTBK2-interacting proteins that cooperate with TTBK2 in this process. In
addition, we will characterize the role of TTBK2 in mediating cilium stability by suppressing cilium
disassembly networks. Second, we will define the mechanisms through which TTBK2 maintains neural
function within the adult brain. We find that mice in which Ttbk2 has been removed from adult tissues
exhibit a neurodegenerative phenotype. In these experiments we will test a set of TTBK2 truncations
that perturb discrete functions of TTBK2 (cilium assembly, cilium stability, or non-ciliary) for their ability
to rescue neural phenotypes in Ttbk2 conditional mutant mice. We will also examine whether proteins
we identify as components of the distinct TTBK2 regulatory networks are required for neural function.
Upon completion of these aims, we will have a greater understanding of the cellular pathways by which
Ttbk2 controls cilia formation, and of the links between cilia regulation, neural function, and the biology
of neurodegenerative conditions.

Public health relevance
Primary cilia are antenna-like structures that play an essential role in human health by regulating key cellular signaling pathways, however, the pathways that control the assembly of primary cilia are unknown. We have identified a protein, TTBK2, that plays a critical role in regulating cilium assembly. In our proposed studies, we will use TTBK2 as molecular handle to dissect the cellular networks that govern cilium assembly, and stability, and to understand the role of cilia in neuronal function.